Project 2: Targeting Specific Lipid Species that Drive Ferroptosis Resistance

Project Summary
Knowledge of the mechanisms that tumors use to subvert ferroptosis remains a gap. We discovered that breast
and liver cancers use two lipids to prevent ferroptosis—coenzyme Q10 and oleic acid. Breast, liver, and other
cancers upregulate key enzymes involved in producing the ferroptosis-blocking lipid coenzyme Q10. While CoQ10
functions in the mitochondrial electron transport chain, it also suppresses ferroptosis by blocking lipid
peroxidation. Normalizing CoQ10 abundance enables ferroptosis to occur. In addition, the monounsaturated fatty
acid (MUFA) oleic acid suppresses ferroptosis, once incorporated into phospholipids. We hypothesize that oleic
acid competes with PUFAs for incorporation into phospholipids, reducing the concentration of PUFA-containing
phospholipids in membranes. We propose to define how CoQ10 and oleic acid block ferroptosis in breast and
hepatocellular (HCC) cancers using a variety of models and samples. These studies will provide new insights
for restoring ferroptosis-mediated tumor suppression in specific cancer contexts, and provide a paradigm for
understanding how cancers subvert ferroptosis. These studies will integrate with Projects 1 and 3 to answer
three overarching questions: how does ferroptosis engage distinct PL species, how does cancer signaling
regulate lipid-metabolism, and how does lipid-metabolism-mediated ferroptosis surveillance contribute to cancer
progression and to treatment strategies.

Public health relevance
Project Narrative In Project 2, we discovered that breast and liver cancers use two lipids to prevent ferroptosis. We propose to define the mechanism by which these lipids block ferroptosis. These studies will provide insights for restoring ferroptosis-mediated tumor suppression in subsets of breast and liver cancers.